PHASE III TRIAL OF OROS METHYLPHENIDATE

This multicenter study intends to establish the safety and efficacy of an oral osmotic dosage form of Ritalin (OROS). Children with ADHD will be screened and diagnosed (#9548A) and, not currently taking MPH, titrated to appropriate OROS dose (9548B). The experimental stage will be a randomized double-blind comparison of OROS, standard Ritalin, and placebo (9548C). Finally, a year of OROS treatment will be provided to evaluate long-term safety and efficacy (9548D).